Plate reader assays to forensically assess exposure of plasma and serum to thawed conditions

Project Summary/Abstract
High quality (pre)clinical research relies on the use of high quality biospecimens; without the latter it is
impossible to have the former. Unfortunately, cancer-relevant clinical analytes from all major biomolecular
classes exhibit instability when the plasma or serum (P/S) in which they reside is temporarily exposed to
thawed conditions (i.e., temperatures > -30 °C). Though the percentage of biomolecules that exhibit instability
under commonly encountered thawed conditions is generally low (e.g. 2-20%), the number of genuine
biomarkers waiting to be discovered is orders of magnitude lower—meaning that in mistreated samples the
number of false leads (i.e., potential false discoveries) is orders of magnitude greater than the number of bona
fide biomarkers waiting to be found. For this reason, every year, poor pre-analytical sample handling and
storage generate unacceptably large numbers of costly false leads in biomedical research. Unsurprisingly,
experts in the field agree that this problem must be minimized immediately.
Under NCI (IMAT) support (R33CA217702) we recently developed a simple, inexpensive, rapid assay requiring
10 µL of P/S known as ΔS-Cys-Albumin that provides an estimate of the amount of time that archived plasma
or serum samples have spent at the equivalent of room temperature. This assay works very well but it requires
an expensive liquid chromatograph-mass spectrometer (LC-MS) instrument and user expertise to run it. The
need for LC-MS limits its availability to most biomedical research labs which further dis-incentivizes its use
beyond the limited incentives that most investigators already have to conduct quality control (QC) analysis on
their P/S samples. Fortuitously, we have discovered that the ex vivo biochemistry that governs the ΔS-Cys-
Albumin marker can be accessed via plate reader-based absorbance or fluorescence measurements.
Converting the ΔS-Cys-Albumin assay to a plate reader-based format would put P/S QC at the fingertips of
nearly all biomedical research scientists. As such, the goal of this project is to develop and analytically validate
plate reader-based absorbance and fluorescence assays that effectively substitute for the ΔS-Cys-Albumin
assay. This will be done via two Specific Aims:
Specific Aim 1: Develop plate reader-based absorbance and fluorescence assays that, by quantifying low
molecular weight thiol and disulfide-bearing molecules in P/S, will be able to detect exposure of plasma and
serum specimens to thawed conditions (i.e., temperatures > -30 °C).
Specific Aim 2: A) Analytically characterize the assays and perform an initial analytical validation of them. B)
Conduct a small population survey of fresh P/S samples and time course aliquots thereof from GI cancer
patients and cancer-free age/gender matched controls to begin to link these assays to P/S exposure time to
thawed conditions at -20 °C, 4 °C, and 23 °C.

Public health relevance
Project Narrative Exposure of blood plasma/serum (P/S) biospecimens to temperatures above their freezing point of -30 °C can dramatically impact clinical research results—a phenomenon that has been shown to produce inordinate numbers of false leads in biomedical research. Well over 100 NIH-sponsored extramural grants employ pre- existing P/S—yet, surprisingly, no criteria for establishing pre-existing sample integrity have been set and no quality thresholds exist that must be met before NIH/NCI (taxpayer) funds are spent on studies involving pre- existing P/S. This project will develop and analytically validate simple plate reader-based assays based on established ex vivo biochemistry that will put the means to assess P/S integrity in the hands of nearly every biomedical research scientist—making it possible for governing bodies to require evidence-based quality control of P/S samples employed in biomedical research.